Tai Chi Exercise and Wearable Feedback Technology to Promote Physical Activity in ACS Survivors

Project Summary/Abstract
Physical activity (PA) is a cornerstone of secondary prevention after an acute coronary syndrome (ACS) with
associated improvements in cardiovascular risk, morbidity, and mortality. Unfortunately, over 80% of these
cardiovascular patients remain sedentary after an event. Participation in cardiac rehabilitation programs is
poor, and long-term adherence to PA remains problematic. There is a critical need for the development of
novel exercise programs to improve PA in this high-risk patient population.
Tai Chi (TC) is a multi-dimensional intervention that integrates low-moderate intensity physical exercise with
meditative components that have been shown to improve important self-regulatory skills and cognitive-
behavioral determinants of behavior change, such as self-efficacy, motivation, and emotional health. Because
it is delivered in a class format, TC also fosters social support. Preliminary evidence suggests that TC may
positively impact PA and selected cardiovascular risk factors. TC is an attractive exercise option for ACS
survivors, who are often sedentary or deconditioned. There is also growing evidence supporting the use of
wearable technology (e.g., Fitbit) as an effective behavioral strategy to promote PA. Wearable devices can
utilize evidence-based techniques such as individualized goal setting and feedback in increasing motivation
and self-efficacy for exercise. In patients with cardiometabolic disease, the addition of wearable technology to
structured exercise has been promising to increase moderate-vigorous PA and improve cardiovascular risk.
This application leverages our prior work with TC to promote PA among sedentary ACS survivors, experience
with remote delivery of group-based TC, and experience combining mind-body exercise with wearables (Fitbit).
We propose a multi-site feasibility study as a necessary step in preparation for a future, fully-powered trial
investigating the efficacy of a multi-modal intervention (TC+Wearable) that combines virtual, group TC classes
with an individual wearable device to support overall PA, and thus impact downstream cardiometabolic risk.
The specific aims are: 1) To assess feasibility of a multi-site randomized controlled trial of TC+Wearable plus
enhanced usual care (with cardiovascular risk factor education materials) vs. enhanced usual care alone
among inactive ACS survivors. Feasibility measures will include recruitment and retention; intervention
acceptability, adherence, and fidelity; and coordination/management of multi-site data collection. Patient-
centered outcomes will include accelerometry-assessed PA and sedentary time, cognitive-behavioral
constructs (self-efficacy, intrinsic motivation, awareness, anxiety/depression, stress), and cardiometabolic
measures (exercise capacity, weight, lipids, blood pressure, glucose). 2) To obtain qualitative feedback from
multiple stakeholders to inform future study conduct. We will engage patients, providers, and TC instructors in
interviews/focus groups on acceptability of TC+Wearable (content, facilitators/barriers, integration of TC and
device); technical aspects of remote delivery; and openness for future provider and TC instructor engagement.

Public health relevance
Project Narrative Physical activity is an important component in the secondary prevention of cardiovascular morbidity in individuals after an acute coronary syndrome. Two promising approaches to promoting physical activity include 1) Tai Chi exercise that is suitable for sedentary individuals, and 2) wearable technology that tracks and provides feedback of activity. This application investigates an intervention that combines remote Tai Chi exercise classes with a Fitbit to promote an increase in overall physical activity that has the potential to significantly impact cardiovascular risk and morbidity in high-risk individuals.